KINETIC AND SPECTROSCOPIC STUDIES OF NUCLEIC ACIDS

The ultimate goal of this research is to characterize the forces directing nucleic acid chemistry. The conformations, thermodynamics and dynamics of oligonucleotide double helices will be investigated as a function of environemtn. A versatile, sensitive laser temperature-jump instrument will be developed to allow dynamics to be measured from 1 ms to 100 ms. The results will help us understand the details of processes such as protein synthesis, gene regulation, and drug binding to nucleic acids.